TREM-1 therapy for the treatment of empyema

Project Summary/Abstract
The incidence of empyema is increasing and associated with a mortality rate of 20% in patients older
than 65 years. About 30% of patients with advanced empyema have contraindications to surgery, showing
an urgent need for novel approaches. The long-term goal of this project is to develop first-in-class TREM-1
therapy for empyema to be used standalone or in combination with single chain tissue plasminogen
activator (sctPA, or alteplase) to decrease fibrinolysin dose, minimizing risk of hemorrhagic complications.
Parapneumonic effusion and empyema are associated with amplified, acute inflammatory response
largely mediated by activated macrophages and neutrophils. TREM-1 is overexpressed on these cells upon
inflammation and amplifies inflammatory response. TREM-1 mediates cytokine release and is involved in
acute and chronic inflammatory disorders, which implicates TREM-1 as a promising target in inflammation.
Targeting TREM-1 in rodent empyema and pneumonia models resulted in a decrease in the
inflammation and pleural injury and an increase in the survival. However, current TREM-1 blockers all
attempt to block binding of TREM-1 to its unknown ligand(s) and have a risk of failure in the clinic. One of
such blockers, LR12 peptide developed by Inotrem (France), recently failed in Phase IIb sepsis trial.
To minimize risk of failure in the clinic, we developed a ligand-independent TREM-1 inhibitory peptide
sequence GF9 that can be used in a form of free peptide GF9 or as a part of trifunctional peptide GA31
formulated into macrophage-specific lipopeptide complexes (LPC) to improve its half-life and targeting.
The hypothesis of this Phase I project is that ligand-independent TREM-1 therapy can be developed as
an effective treatment for empyema to suppress inflammation and reduce mortality and morbidity.
Earlier, we showed that GF9 and GA31-LPC inhibit inflammatory cytokine release, protect against septic
shock and reverse lung fibrosis in mice. Phase I aims to test if these agents attenuate pleural and systemic
inflammatory responses in a Streptococcus pneumoniae-induced rabbit model of acute empyema that
recapitulates human disease. Considering pros and cons of GF9 and GA31-LPC, we suggest to test both.
Specific aims of this project are to: 1) generate and characterize in vitro GMP-friendly GF9 and GA31-
LPC injectables, and 2) test GF9 and GA31-LPC comparatively in a rabbit model of acute empyema. We
will synthesize and characterize GMP-friendly GF9 and GA31-LPC for their composition, size, stability, and
inhibitory effect on cytokine release by LPS-stimulated U937 macrophages. We will then test two doses of
GF9 and GA31-LPC in rabbits with acute empyema. We will monitor development of empyema and
analyze pleural inflammation and injury. Comprehensive histology/IHC studies will be performed.
It is anticipated that this Phase I study will identify a novel, first-in-class, well-tolerable agent as a
powerful platform for development of safe and effective therapy capable of treating empyema.

Public health relevance
Project Narrative The incidence of empyema has steadily increased over the past decades with an annual US healthcare cost of over $500M and mortality >20% for patients older than 65. In order to increase efficacy of empyema treatment, we will target inflammation with TREM-1 inhibitors alone and in combination with a fibrinolysin in a validated animal model of empyema. The proposed research is anticipated to result in the development of novel mechanism-based, effective and well-tolerable therapy to substantially improve clinical outcome and reduce the mortality rate in patients with empyema.